Repurposing Styrene Catabolic Enzymes for the Synthesis of Penicillins

Abstract
Penicillins represent one of the most impactful antibiotics in use for the resolution of gram-positive bacterial
infections including bacterial meningitis, diptheria, strep throat, syphilis, gonorrhea, and yaws disease that afflict
more than 6 million people annually. These antibiotics are frequently in short supply and improved production
methods are needed that both increase the accessibility while reducing inefficiency and environmental impacts
associated with current production methods. The primary route to the commercial production of penicillins begins
with batch fermentation of the fungus, P. chrysogenum as a biosynthetic route to 6-aminopenicillanic acid (6-APA),
which is subsequently used as a starting material for the synthesis of b-lactam antibiotics. As an alternative to
currently employed organic synthetic routes to amidation of 6-APA, chemoenzymatic synthetic methods based on
the amidation of 6-APA by penicillin amidases (PAs) or isopenicillanic acid transferases (IATs) provide a competitive
green chemical approach to penicillin-based antibiotics. Each chemoenzymatic approach poses unique challenges.
The amidase-catalyzed acylation of 6-APA requires the use of chemically activated carboxylic acid derivatives as
substrates and proceeds with low transformation efficiency. IATs on the other hand are dependent on phenylacetyl-
Coenzyme A ligases, which have low stability and limited substrate specificity.
In the present work we target an alternate chemoenzymatic strategy for the synthesis of penicillins from
aldehydes by joining the activities of IAT and an engineered thiol-acylating aldehyde dehydrogenase (TAD). The first
specific aim of this work will target the selective introduction of mutations in the catalytic active site of
phenylacetaldehyde dehydrogenase (NPADH) from Pseudomonas putidia (S12), which has a broad aldehyde
specificity. Mutations will target the transformation of NPADH into a TAD for the synthesis of the N-acetylcysteamine
(SNAc) thioesters. In our second aim, SNAc thiosesters, which are surrogates of acyl-CoA will be introduced with 6-
APA co-substrates in the IAT-catalyzed synthesis of penicillins. This strategy is expected to result in a high product
yield while eliminating the limitations associated with the phenylacetyl CoA ligases. The development this process
will serve as prototypical green-chemistry pathway that can be further expanded into a platform for the production
of existing and new classes of b-lactam antibiotics.

Public health relevance
Project Narrative: Penicillins are essential antibiotics for the resolution of gram-positive bacterial infections. The development of chemoenzymatic strategies for the green chemical synthesis of penicillin-class antibiotics can help to increase their availability and decrease the cost of production. In the present work we join the activities of an engineered aldehyde dehydrogenase from the bacterial styrene catabolic pathway and the fungal isopenicillanic acid N-acyltransferase to generate a new route for the synthesis of penicillins from 6-aminopenicillanic acid and aldehyde stating materials.